Mechanisms of mitochondria-driven hepatocyte injury

PROJECT SUMMARY
The prevalence of metabolic disease is growing rapidly, driven predominantly by increasing incidence of obesity
and metabolic-associated steatohepatitis (MASH). However, there are very limited therapies for treating liver
injury, placing these as a growing area of unmet clinical need. One therapeutic approach for metabolic diseases
has been to seek human gene variants conferring susceptibility or protection. Unfortunately, several of the top
genetic targets have phenotypes in model systems that do not replicate human pathology, have loss-of-function
phenotypes associated with higher injury risk, or are associated with worsening cardiovascular risk, complicating
the development of drugs. Here, we propose to study a gene, EF-hand domain family member D1 (EFHD1),
whose decreased hepatic expression in genome-wide analyses has been associated with protection from liver
injury in multiple, racially-diverse human populations. The EFHD1 protein is targeted to the mitochondrial outer
membrane, including areas interacting with the endoplasmic reticulum, and possesses Ca2+-binding EF hands.
We find that mice without EFHD1 (Efhd1-/-) have no obvious adverse phenotypes at baseline, but are protected
against liver injury during a metabolic challenge, replicating the human phenotype. Therefore, inhibiting EFHD1
may be a promising therapy for liver injury. Moreover, a widespread phenomenon noted in many organs,
including the liver, is that overnutrition causes excessive mitochondrial fission through the release of Ca2+ from
the ER. However, the critical transducer coupling ER Ca2+ release to mitochondrial fission has not been identified,
despite decades of study. Here, we hypothesize that EFHD1 is, in fact, that critical transducer, providing a
mechanistic understanding for why inhibiting it may be potentially beneficial in MASH. Our proposal comprises
three aims. First, we will define whether EFHD1 is the critical adaptor facilitating Ca2+-dependent mitochondrial
remodeling. Second, we will determine if loss of EFHD1 leads to altered fatty acid oxidation. Finally, we will test
whether loss of EFHD1 is protective against hepatocyte damage and subsequent inflammatory responses in
mouse models of MASH and liver injury. Our collaborative team of investigators combines expertise in
mitochondrial Ca2+ signaling, mouse and human studies of liver disease, and rigorous metabolic phenotyping,
and is well-poised to tackle this project. In summary, the series of experiments detailed in this proposal will
reveal the mechanism of EFHD1 action, and establish whether targeting this pathway may be protective against
liver injury, as seen in human genetic analyses.

Public health relevance
PROJECT NARRATIVE Mitochondria that fission excessively are often found in livers injured by overnutrition and metabolic diseases, and may contribute to pathology. Here, we identify a critical transducer of hepatocyte mitochondrial fission, and investigate whether inhibiting it can be protective in animal models of liver disease.